COG NCTN Network Group Operations Center - Clinical Trials Development Core

PROJECT SUMMARY This is the Clinical Trials Development Core to support the overall application for the COG NCTN Network Group Operations Center.